2023 Cancer Genetics and Epigenetics GRC & GRS

SUMMARY
The 2023 Conference on Cancer Genetics and Epigenetics will highlight the new development, challenges and
opportunities in precision cancer medicine. The conference will focus on emerging technologies and analytical
computational methods deciphering mechanistic insights from the studies of individual cancer genome and
epigenome leading to drug discoveries and novel precision therapeutics. Heterogeneity of cancer and
evolutionary trajectory of cancer will be explored in the context of genetics, epigenetics as well as genome
topology, enabled by modern technologies including single cell genomics and CRISPR-based genome and
epigenome engineering tools amenable to studies in tumor samples. An emphasis will be put on the emerging
roles of non-coding genome and epi-transcriptome in cancer, and how they inform novel therapeutic strategies.
Challenges in designing future generation cancer genomics studies and integrating large cancer genomics data
will be addressed. This meeting should appeal to a wide range of cancer researchers, molecular biologists, and
bioinformaticians seeking to apply the latest genetics and epigenetics discoveries to their work to cancer. In
addition to an outstanding set of invited speakers there will be several interactive poster sessions, one minute
"poster preview" talks and several talks selected for platform presentation from the submitted abstracts.

Public health relevance
Narrative The 2023 Gordon Research Conference on Cancer Genetics and Epigenetics brings together senior, and junior scientists to present the latest findings in how changes in genomes, chromatin structure and function and gene expression and chromatin lead to cancer. Plenary talks, short talks selected from submitted abstracts and poster sessions are accompanied by robust discussion to stimulate new pathways of research and new collaborations.